Characterizing EZH1 Gain of function mutations to understand neurodevelopmental disease and inform EZH1-inhibitor innovation

PROJECT SUMMARY/ABSTRACT:
Neurodevelopmental disorders (NDDs) represent a diverse array of conditions characterized by abnormal
brain development and function which cause motor, cognitive, and communicative deficits that greatly impact a
patient’s quality of life. However, many underlying disease mechanisms are still unknown, resulting in a dearth
of effective treatments and an urgent need to better understand NDDs.
One challenge of studying NDDs and developing effective treatments however is that many NDDs are
multifactorial with both an individual’s genetics and environment playing key roles. Attributing a single disease
mechanism to a patient phenotype can therefore be extremely difficult. Consequently, one approach to
circumvent this is by focusing on NDDs with a singular and well-defined genetic cause. To this end, the Akizu lab
recently identified a novel NDD caused by heterozygous missense mutations in Enhancer of Zeste Homologue
1 (EZH1) which is one of the two catalytic subunits within the Polycomb Repressive Complex 2 (PRC2) that is
responsible for transcriptional repression through tri-methylation of the lysine at position 27 of histone H3
(H3K27me3). Initial mechanistic work identified several mutations that increase the catalytic activity of EZH1 and
subsequent H3K27me3 levels, indicative of a gain-of-function (GOF) effect. Follow-up experiments further
revealed that one GOF mutation p.A678G induces premature neuronal differentiation and enhanced maturation
during the differentiation process along with a downregulation of glutamatergic synapse genes that together may
potentially produce dysfunctional neurons. However, several unanswered questions remain such as whether the
remaining 10 uncharacterized EZH1 missense mutations are GOF, if the previously characterized phenotype
extends to other validated GOF mutations and also induces neuronal dysfunction, and whether EZH1-specific
inhibitors can ameliorate these effects. This proposal therefore aims to answer these questions and gain further
insight into the EZH1 GOF phenotype and relevant treatment strategies, advancing our understanding of NDD
disease mechanisms and therapeutic approaches to help afflicted patients.
The proposed research will also provide the applicant with intensive training in imaging and molecular
methodologies; rigor and reproducibility; experimental design; and scientific communication. Furthermore, the
applicant will be supported by a team of experts headed by the sponsor Dr. Naiara Akizu and also including Dr.
Ethan Goldberg, Dr. Ana Cristancho, and Dr. George Burslem. Finally, the resources available at both the
University of Pennsylvania and the Children’s Hospital of Philadelphia will ensure the successful completion of
the proposed research and training of the applicant and will help fulfill their desire to become an independent
research professor of neuroscience.

Public health relevance
PROJECT NARRATIVE: Neurodevelopmental disorders (NDDs) can cause motor, cognitive, and communicative issues due to abnormal brain development that can significantly impact a patient’s well-being. As a result, understanding the genetic and molecular mechanisms of NDDs is integral to improving public health as this enhanced knowledge can greatly benefit diagnostics, disease maintenance, and even therapeutic development. Our study therefore implements a human pluripotent stem cell (hPSC) model system to further investigate the EZH1 GOF phenotype and develop EZH1-specific therapeutic strategies to ameliorate NDD symptoms.